ALGORITHMS AND SOFTWARE FOR SEQUENCING BY HYBRIDIZATION

Sequencing by Hybridization (SBH) is a challenging alternative to the classical DNA sequencing methods. Several SBH problems must still be jointly addressed by biochemists, computer scientists and instrument designers. In this proposal we address computer science aspects of SBH and hope to bring these communities into closer contact. Some unsolved computer science problems seriously slow down the development of biochemical and instrumentation aspects of SBH. In close collaboration with biology and instrumentation SBH groups we identified the most important computer science problems which need to be addressed to benefit the further development of SBH. The proposal describes a project to study these problems. * User-friendly SBH software in public domain within the first year. * Algorithms and software for sequence reconstruction by optimized chips. * Algorithms and software allowing biologists to check their hypothesis and to optimally choose additional biochemical experiments for SBH. * Algorithms and software to eliminate "blind" choice of PCR primers by SBH data and reduce the amount of conventional sequencing in molecular evolution studies. * Algorithms and software to combine small-scale SBH and primer walking DNA sequencing and to parallelize ordered sequencing strategies. * Computational analysis of PCR-SBH and estimation of resolving power of PCR-SBH.